Origins And Outcomes Of Smartphone And Social Media Habits Across Development Supplement

Supplemental Proposal Abstract to: “Origins and Outcomes of Smartphone and
Social Media Habits Across Development”
This proposal is a diversity supplement that seeks to extend the objectives of the parent
project (Chein, R01 HD098097) by recruiting participants from the original
developmental cohorts during the period between longitudinal Waves 1 and 2 to
investigate how digital media habits, goal states, and social sensitivity may interact to
shape memory for recently experienced events. The ubiquity of smartphone and social
media use in kids’ and teens’ lives has made it crucial to understand the impacts that
these habits may have on subsequent development and in particular, how these habits
shape memory systems. Critically, this work will address important limitations in prior
research surrounding the impact of digital media use on subsequent memory, which has
too often been atheoretical and offers mixed conclusions about how engaging in digital
media use during an experience can subsequently affect memory for the experienced
events. The proposed study will be the first to apply current memory-based theories of
hippocampal-mesolimbic functioning to the digital media domain, and in so doing, will
provide a novel window into how digital media use shapes memory at different periods
of development. Across both aims of the present proposal, an extensive battery of
indices acquired from the parent project relating to habitual patterns of digital media
engagement and social sensitivity will be leveraged to predict episodic memory
performance. Using a within-subject design, participants from each cohort (ages 8-10,
13-15, and 18-20) will be imbued with different learning goals as they view a series of
news segment videos. Memory for the videos will be assessed as a function of goal
states, digital media habits, and social sensitivity. The outcomes of the proposed project
will be interpreted through the lens of memory-based theories to provide key insights
into how the intensified presence of digital media in everyday life affects memory across
development.

Public health relevance
PROJECT NARRATIVE Dramatic increases in the ubiquity of smartphone and social media use in kids’ and teens’ lives have made it crucial to understand the impacts that these habits may have on subsequent development and everyday functioning. The proposed project will extend a recently launched multi-methodological cross-sequential longitudinal parent project to investigate how digital media habits, goal states, and social sensitivity may interact to shape memory for recently experienced events at different stages of development. Findings from this research will shed light on how engaging in digital media use during an experience may shape memory for experienced events, as well as how individual differences in motivation and social sensitivity may mediate differences in subsequent memory.